Administrative Core

Core C Is the Administrative Core. Its functions include broad management of the Program, including financial management, coordination of activities with scientific collaborators, periodic reviews of overall Program activities, and management of report writing and publications. In addition this Core has responsibility for Data Management and maintenance of statistical software.

Public health relevance
Inflammation is now recognized as a major factor in the etiology of many types of cancer. The proposed research will open new understanding of the role of the chemical changes to proteins and DNA brought about by the immune cells attracted to the site of inflammation. The overall chemical damage contributes strongly to the process leading to cancer.